Kisspeptin Physiology in the Human

In reproduction, all environmental and endogenous cues ultimately converge upon the single common neuroendocrine pathway of gonadotropin-releasing hormone (GnRH) from the hypothalamus and its stimulation of luteinizing hormone (LH) and follicle stimulating hormone (FSH) from the pituitary. GnRH has traditionally been thought of as the first step in the reproductive cascade; its commanding role in this biological hierarchy allows it to control pulsatile gonadotropin secretion, modulate gonadal steroid feedback, and ultimately determine the initiation of pubertal development and fertility. In 2003, we reported that, in both the human and the mouse, mutations in GPR54 cause a failure of the normal patterns of pulsatile GnRH release and hypogonadotropic hypogonadism. The ligand of GPR54 is kisspeptin--the impact of kisspeptin/GPR54 on GnRH secretion is well conserved across mammalian species; it is a genetic determinant and indisputable gatekeeper of normal reproductive function. Kisspeptin is a powerful stimulus of GnRH secretion and is a vital agent for activating the hypothalamic pituitary gonadal axis. . This grant will now explore the physiology of the kisspeptin pathway using the human as the model organism. The first specific aim explores the protein expression of kisspeptin using carefully assembled hypothalamic specimens from individuals representing all phases of reproductive life, including the mini-puberty of infancy, the childhood quiescence, the pubertal transition, reproductive maturity, and menopause. The second specific aim utilizes kisspeptin to interrogate of the GnRH neuron in vivo. Administration of kisspeptin to meticulously phenotyped and genotyped patients with hypogonadotropic hypogonadism will allow assessments of the functional integrity of the GnRH neuron, including the properties of GnRH neuronal fate specification, peptide synthesis and release. The third specific aim employs diverse methods of kisspeptin administration to selectively manipulate the reproductive cascade (selective, reversible suppression or sustained stimulation) and explore its role as a potential therapeutic target.

Public health relevance
Our team is driven to discover the genes that control the timing of puberty and reproductive function in the human. Using genetic tools, we uncovered a ligand - receptor pathway (kisspeptin - GPR54) that appears to play this critical role in this process. Kisspeptin, acting through GPR54, stimulates the release of another hypothalamic hormone, GnRH, which triggers the reproductive hormonal cascade. The main focus of this grant is to study physiology of the kisspeptin GPR54 pathway using the human being as the model organism and to explore the possibility that kisspeptin could be a therapeutic target for patients with reproductive diseases. The first goal of this grant will be to study the expression of kisspeptin in human hypothalami from individuals across the reproductive lifespan, beginning with neonatal life all the way through to menopause. The next goal will be to administer kisspeptin to patients with abnormalities in pubertal development to probe the function of their GnRH neurons. The final goal will be to give kisspeptin via different routes of administration and determine whether this peptide could be a possible therapy in patients with reproductive disease.